BIOSTATISTICAL CORE

Statistical support for the Program Project will be provided through the Biostatistical Core. Dr. Richard Raubertas (CV included), who has worked extensively with us in the past and is a member of our internal Advisory Committee, will supervise the statistical core. He will operate from the Department of Biostatistics, School of Medicine and Dentistry. This Department if well-staffed by faculty, computer programmers and research associates. In addition, the Department has 2 NIH supported post-doctoral training programs. The Department has up-to-date computer hardware and software, including networks of Unix and Windows NT workstations; SAS and S-plus statistical software; and SQL server database software (see Biostatistics ore Resources, pages 81-82).